Can risk-reducing medications improve breast cancer prevention in childhood and adolescent cancer survivors? Comparative modeling to inform care

PROJECT SUMMARY/ABSTRACT
Survivors of childhood and adolescent cancer (“survivors”) face high risks for early mortality and treatment-
related late effects, including subsequent breast cancer. Approximately 30% of female survivors previously
treated with chest radiation will develop breast cancer before age 50, a risk similar to BRCA1 mutation carriers.
The Children’s Oncology Group recommends early screening for breast cancer (in those who received
radiation) starting at age 25, but <15% of survivors are adherent, many because of economic barriers. Risk-
reducing medications, such as selective estrogen receptor modulators and aromatase inhibitors, could allow
some survivors to avoid breast cancer entirely (vs. early detection with screening and treatment) since these
drugs reduce the risk of estrogen receptor positive (ER+) tumors by 50% and are recommended for high-risk
women by the U.S. Preventive Services Task Force. However, risk-reducing medications are not currently
standard care for high-risk survivors which includes not only those previously treated with radiation but given
emerging data, those who were exposed to high doses of anthracycline chemotherapy. The rarity of childhood
and adolescent cancer and the long latency needed to capture subsequent cancers limit the feasibility of
prospective prevention trials. Addressing all RFA-CA-20-027 priority areas, we propose to use simulation
modeling and longitudinal observational data to inform clinical care by evaluating the clinical benefits and
harms of risk-reducing medications among childhood and adolescent cancer survivors. We will build on our
established collaboration with the Cancer Intervention and Surveillance Modeling Network (CISNET), the
Childhood Cancer Survivor Study (CCSS) and the St. Jude Lifetime Cohort Study to: (1) refine two CISNET
models to reflect current knowledge on breast cancer risk, screening and prevention among survivors; (2)
provide model results in readily accessible online look-up tables summarizing benefits (e.g., avoiding breast
cancer), harms (e.g., medication side effects) and costs to women and society of adding risk-reducing
medication use for 5 years to screening; and (3) conduct exploratory analyses to assess the impact of risk-
reducing medications and screening on outcomes by race. Our proposed research will have high potential to
reshape current paradigms for survivorship care, using breast cancer risk-reducing medications as an example
for understanding how preventive agents can be incorporated into current survivorship recommendations and
practice. This work will also provide a framework to illuminate key elements and intervention points that can
guide efforts to minimize disparities. This project is conceptually innovative and clinically important by
simultaneously considering proven effective primary cancer prevention medicines together with screening
recommendations. This work will be highly translational by providing data to inform clinical care guidelines and
create resources that survivors and care-providers can use to guide care discussions on breast cancer
prevention and early detection.

Public health relevance
PROJECT NARRATIVE Risk-reducing medications such as tamoxifen and aromatase inhibitors can reduce breast cancer risk among survivors of childhood and adolescent cancer but are not currently standard care for these high-risk women. By using simulation modeling and longitudinal observational data, we will provide estimates of the clinical benefits and harms of risk-reducing medications among high-risk survivors to inform follow-up care guidelines and discussions. This work will reduce morbidity and improve care for survivors by broadening the focus of survivorship care to include primary prevention alongside screening and creating resources that can facilitate care discussions between survivors and care-providers about breast cancer prevention and early detection.